Prenatal metal exposures and childhood telomere length attrition

SUMMARY ABSTRACT
Accelerated biological aging poses significant risks to health and mortality, yet the underlying factors remain
poorly understood. Telomere length (TL), a biomarker of biological aging, is inversely associated with
chronological age and indicative of aging-related disease susceptibility. Telomeres shorten more rapidly during
the first two decades of life due to accelerated physical growth, particularly in infancy and adolescence.
Childhood exposures have been linked to TL in later life, emphasizing the importance of these developmental
periods in influencing later-life health trajectories. While prenatal toxic metal exposures are associated with TL
in infancy, there is limited understanding of the association between essential metals and TL. The gut microbiome
(GM) is another important component of healthy aging, with recent studies indicating an association between
GM composition in childhood and TL. GM composition is influenced by metal exposures, and the GM also
influences xenobiotic toxicity. Specific metal- and metal-microbial cliques, subgroups of metals and microbes,
may be associated with TL attrition, as not all metals and all gut microbes likely influence TL jointly. The concept
of cliques provides a unique measure to assess associations lying between individual components and mixtures.
However, few, if any, studies have investigated the complex associations between metals, microbes, and
longitudinal TL attrition from birth to late childhood. Given the potential links between metals, microbes, and TL,
we hypothesize that mixtures of metals and specific metal-microbial cliques are associated with TL attrition. The
long-term goal of this work is to better understand the interactions between environmental exposures and GM
on health and aging across the lifespan. Our overall objective is to investigate and model the complex interactions
among prenatal metal exposures, GM, and their influence on TL attrition from early to late childhood. The
proposed study will employ a robust methodology, utilizing mixture methods, interpretable machine learning, and
causal inference, and will draw on data from the well-characterized pediatric cohort in Mexico City. Specific
objectives include identifying associations between prenatal metal exposure mixtures and biological age
acceleration, pinpointing subgroups of children susceptible to accelerated TL aging based on metal cliques,
exploring interactions between prenatal metals and childhood gut microbiome cliques in late childhood, and their
association with TL in childhood. Our study team is highly motivated and well-positioned to complete the
proposed study. Despite the complexity of the project, its significance lies in paving the way for targeted
interventions aimed at preventing adverse health outcomes from an early developmental stage by identifying
early targets for metal and microbial interventions. This research is part of a broader continuum, aiming to
address the complexities of accelerated biological aging for long-term health benefits.

Public health relevance
PROJECT NARRATIVE This grant aims to investigate how prenatal metal exposures and the childhood gut microbiome (GM) interact with telomere length (TL) attrition from birth to late childhood using secondary data from a well-characterized longitudinal birth cohort in Mexico City, pinpointing specific periods of childhood vulnerability to biological age acceleration. Using exposure mixture modeling and interpretable machine learning techniques, the project aims to identify subgroups of children most susceptible to TL attrition based on these metal exposures, with further exploration into the role of childhood gut microbes in influencing accelerated aging susceptibility. The anticipated impact encompasses delineating associations between prenatal metals, TL attrition, and the GM, identifying vulnerable subpopulations for targeted interventions, and illuminating potential microbial pathways critical for mitigating accelerated aging and promoting healthy aging strategies.